Adherence Determinants in the Health Electronic Record Evaluation of Statins (ADHERES)

PROJECT SUMMARY
Statins are the cornerstone for preventing and treating atherosclerotic cardiovascular disease (ASCVD), the
leading cause of death worldwide. Yet even the highest-risk patients face challenges initiating and continuing
these low-cost, life-saving medications. Clinicians also fail to prescribe statins when indicated, and health
systems may lack the infrastructure to systematically monitor statin adherence. Thus, the objective of the
proposed study, Adherence Determinants in the Health Electronic Record Evaluation of Statins (ADHERES), is
to determine reasons for statin nonuse across diverse populations as a strategy to reduce health
disparities. Specifically, this study will fill the knowledge gap of why certain patient groups (historically
marginalized racial and ethnic groups, women, and older adults) are less likely to use statins by leveraging
electronic health record (EHR) data and targeted focus groups.
Statin use is typically collected in discrete, structured EHR data fields. However, structured EHR data may be
incomplete, lack vital information about shared decision-making available around statin use, and fail to capture
the variety of reasons for statin nonuse. A better understanding of the patient, clinician, and health system factors
associated with statin nonuse thus requires the simultaneous study of structured, unstructured, and patient-
generated EHR data from different data sources and patient populations, and ascertaining patient and clinician
perspectives through qualitative approaches.
To tackle this challenging public health problem, a multidisciplinary team that includes experts in preventive
cardiology, health equity research, biomedical informatics, implementation science, community partnerships,
and qualitive methods has been assembled. EHR data sources include ~3 million eligible patients from Stanford
Health Care, the Veterans Health Administration, and Houston Methodist. Aim 1 will characterize gaps in
guideline-directed statin use across diverse patient groups and clinical indications using structured and
unstructured EHR data and identify patient profiles and characteristics linked to statin nonuse. Aim 2 will
elucidate reasons for statin nonuse in unstructured EHR and patient-generated health data using large language
models. Aim 3 will validate and extend these reasons and co-design solutions to improve statin adherence
through 10 patient (n=80 participants) and 4 clinician (n=20 participants) focus groups in partnership with the
National Minority Health Alliance, a nonprofit organization committed to eliminating health disparities.
Findings from ADHERES will be directly actionable in all three health systems by more accurately capturing
gaps in guideline-directed statin use, and lead to the implementation of user-centered interventions to address
identified barriers. This multi-pronged approach can be scaled beyond statins to improve adherence and the
equitable use of other guideline-directed, lifesaving cardiovascular treatments.

Public health relevance
PROJECT NARRATIVE Statins are among the most effective medications to prevent and treat heart disease, but they are not prescribed routinely to people who would benefit from them, especially racial and ethnic minorities, women, and older adults. This study will use information from electronic health records and focus groups to identify patient, clinician, and health system barriers to statin use. This approach could be used to increase the use of statins as a way to reduce health disparities for millions of high-risk individuals.